RP3 Administrative Supplement - UAMS - evaluating the effectiveness and cost-effectiveness of Medicaid postpartum coverage extensions (MPE)

Both gestational diabetes mellitus (GDM) and pregnancy-induced hypertension (PIH) affect pregnancy, birth
outcomes, and postpartum care. They are independent risk factors for diabetes mellitus (T2DM), hypertension
(HTN), and mental health conditions such as postpartum depression (PPD). Despite recommendations that
postpartum care should include blood pressure (BP), blood glucose (BG) monitoring, and PPD screening,
current postpartum care practices have low screening rates, especially among Medicaid beneficiaries. While
Medicaid covers nearly half of deliveries in the United States, many birthing people lose coverage 60 days
after birth. The American Rescue Plan Act of 2021 provided states with federal funding to extend postpartum
coverage up to 12 months – Louisiana and Mississippi have done so while Arkansas has not. Additionally, on
August 1, 2022, Louisiana enacted a statewide mandate requiring providers of postnatal care to screen for
PPD and related mental health disorders. Using our collaboration with the National Birth Equity Collaborative
and combined expertise, we propose to evaluate the effects of the Medicaid postpartum extension (MPE) and
PPD screening mandate on screening behaviors, health outcomes, and patient experiences in Louisiana (LA)
compared to Mississippi (MS) and Arkansas (AR). We will link electronic health records and Medicaid claims
data in Louisiana, Mississippi, and Arkansas allowing us to track screening and follow-up care even after
birthing people lose Medicaid coverage. The primary effectiveness measure will be a 3-month composite
screening rate for BP, BG, and PPD. Secondary measures include individual screening rates, diagnoses, and
management of T2DM, HTN, and PPD. It is also critical to understand contextual factors and health inequities
that contribute to disparities in postpartum care and to estimate the cost-effectiveness of these policies. The
overall goal is to evaluate effective implementation strategies that aim to improve maternal postpartum health
in Medicaid beneficiaries with GDM or PIH. To achieve this goal, the study will have three specific aims. First,
we will examine the effectiveness of Louisiana’s and Mississippi’s MPE and Louisiana’s PPD screening
mandate on the rates of BG and BP monitoring, PPD screening, rates of T2DM, HTN, and PPD diagnoses,
T2DM, HTN and PPD management, health disparities, and health care utilization, as compared to counterparts
in Arkansas. The second aim will be to examine the cost-effectiveness and distributional cost-effectiveness of
the MPE and PPD screening mandate from the patient, provider, payer, and social perspectives. The third aim
will be to examine the complex contextual factors that influence adopting and implementing MPE and PPD
screening mandates, and subsequent impacts on healthcare delivery, healthcare utilization, and maternal
health equity within and between Louisiana, Mississippi, and Arkansas. Findings will inform concurrent and
future health policy strategies for informing, engaging, and empowering birthing people to improve maternal
health outcomes and eliminate maternal health disparities in the United States.

Public health relevance
Narrative We will evaluate the effects of the Medicaid postpartum coverage extension in Louisiana and Mississippi, and postpartum depression screening mandate in Louisiana, compared to Arkansas. The intended outcome will be to evaluate the effectiveness and contextual factors of implementation strategies that aim to improve maternal postpartum health and health equity. This study will generate urgently needed data on practical, robust, and sustainable population-targeted strategies to improve maternal health outcomes, reduce maternal health risks, and eliminate maternal health disparities in the United States.